Transcriptional activation of LAMC1 as a resistance mechanism in recurrent PFA Ependymoma

Brain and other tumors of the central-nervous system (CNS) are the most common cancers in children aged 0-
14 years in the USA. Ependymoma (EPN) is the third most common pediatric brain tumor and a leading cause
of death in childhood cancer patients. The most common and aggressive subgroup, posterior fossa
ependymoma group A (PFA), occurs mainly in young children and frequently leads to recurrences. Despite
extensive DNA sequencing studies, the only molecular marker associated with particularly poor survival is gain
of the chromosome arm 1q. The overall objective of this proposal is to identify the molecular mechanisms that
cause the poor survival of 1q+ PFA EPN patients. To approach this objective, we have analyzed the 3D
conformation of 1q+ PFA EPN tumor genomes using HiC. As a result, we identify complex inter-chromosomal
structural variants (SVs) that result in the formation of new topologically associated domains (‘neo-TADs’) leading
to transcriptional activation of LAMC1. Based on these results, we now hypothesize that the transcriptional
activation of LAMC1 by the formation of SV-induced neo-TADs is a common resistance mechanism in recurrent
1q+ PFA EPN tumors. Thus, strategies that target LAMC1 may reveal new vulnerabilities and overcome
resistance to therapy in the treatment of PFA EPN relapse patients. The rationale for this project is that resolving
SVs in a larger cohort of available PFA EPN relapse samples using HiC and functional inhibition experiments
against LAMC1 in relapse PFA EPN models are likely to provide a strong scientific framework in which basic
mechanisms of epigenetically linked activation of proliferation and new therapeutic opportunities can be
identified. The central hypothesis will be tested by pursuing to answer two specific aims: First, we aim to
determine the frequency of SVs in a larger cohort of 1q+ PFA ependymomas and their impact on regulatory
domains (Aim 1). Second, we aim to determine the therapeutic potential of targeting LAMC1 in patient-derived
models of relapse PFA ependymomas (Aim 2). Ultimately, our studies have the potential to improve our
understanding of the epigenetic regulation that drives the acquisition of stemness and resistance to therapy and
to advance the treatment of PFA EPN patients. The research proposed in this application is innovative, in the
applicant’s opinion, because it interrogates a new molecular mechanism of transcriptional LAMC1 activation in
recently derived faithful models of PFA EPN. The proposed research is significant, because it is expected to
provide new therapeutic opportunities for a pediatric brain tumor type that is a leading cause of death in childhood
cancer patients. Ultimately, our studies have the potential to improve our understanding of the epigenetic
regulation that drives the acquisition of stemness and to advance the treatment of diseases.

Public health relevance
The proposed research is relevant to public health as it focuses on the overarching theme of how copy number gains mediate an invasive phenotype by promoting metastasis and tumor progression. In particular, these studies will improve our understanding of complex inter-chromosomal structural variants that activate the expression of oncogenes and promote the acquisition and maintenance of stemness in the third most common pediatric brain tumor type ependymoma. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to the causes, diagnosis, prevention, and cure of human diseases.